DP24-004, PRC, Core: University of Iowa Prevention Research Center for Rural Health

The Prevention Research Center for Rural Health (PRC-RH) mission is to address disparities in and across
Midwestern communities to promote well-being. Among many social, structural, and environmental
determinants of health, place matters. In the US, 97% of land is considered rural, and 19% of the population
live in these places. Rural residents are more likely to die from each of the ten leading causes of death; yet
rural health programs are underfunded.
Place also intersects with other important social identities, including sexual and gender identity, frequently
referred to as LGBTQIA+ (Lesbian, Gay, Bisexual, Transgender, Queer, Questioning, Intersex, Asexual and
additional aspects of sexual/gender identity). LGBTQIA+ individuals are at elevated risk of cancer, chronic
obstructive pulmonary disease, and cardiovascular disease than their heterosexual and cisgender peers. Less
is known about LGBTQIA+ lives in rural areas. Many socio-ecologic factors influence these outcomes including
experiences of stigma and discrimination. These experiences also drive risk behaviors including tobacco use.
Tobacco use is significantly higher among LGBTQIA+ young adults (YA) than their heterosexual and
cisgender peers. Evidence-based cessation strategies, such as Tobacco Quitlines (QL) are available, but YA
significantly underutilize them. QL offer free, convenient, confidential cessation services that can address
barriers in access to treatment. There is a clear implementation gap in evidence about what works to increase
uptake of QL for rural LGBTQIA+ YA who use commercial tobacco products. Community-engaged research
with these YA is necessary to center their narratives, to understand unique barriers to uptake of the QL; and to
design sustainable, culturally relevant, and scalable implementation strategies to increase uptake of the QL.
The PRC-RH focuses on micropolitan communities (n=15) in Iowa (IA); rural communities with populations
sized 10,000-<50,000 that are growing in diversity, and serve as hubs for education, employment, economic
and health activities, and are frequented by residents of smaller rural communities. Our specific aims are:
• Aim 1: Promote health equity in IA’s micropolitan communities. Our approach relies on strengthening
capacity to conduct prevention research; providing training and technical assistance, and infrastructure to
support Aim 2, and communicating, disseminating and translating evidence-based interventions.
• Aim 2: Enhance Quitline uptake and smoking cessation among LGBTQIA+ young adults in Iowa’s
micropolitan communities. This project will pilot test implementation strategies in two micropolitan
communities, develop an Implementation Playbook, scale up the intervention across Iowa, and share
lessons learned and translation products with partners across Region G.
• Aim 3: Collaborate with other PRCs in the network and other external partners to co-learn, synergize,
share successes, and disseminate and translate products for collective health equity impact.

Public health relevance
Project Narrative Young adults (YA) in rural areas who identify as Lesbian, Gay, Bisexual, Transgender, Queer, Questioning, Intersex, Asexual and or other aspects of sexual and /gender minority identities (LGBTQIA+) disproportionately use tobacco products and underutilize effective cessation programs. In keeping with the Prevention Research Center for Rural Health’s mission to address health disparities and promote wellbeing in rural communities, our research project partners with LGBTQIA+ YA, state and community partners to identify effective implementation strategies for increasing the use of the Tobacco Quitline, an evidence-based intervention.